In Vivo Neuronal Reprogramming of Fibroblasts After Spinal Cord Injury

SUMMARY
Neuron loss is a frequent result of spinal cord injury (SCI). A fundamental but unresolved challenge is how to
restore the lost neurons and repair the neural circuits after SCI. Stem cell-based transplantation has limitations
on immune compatibility, neuronal survival, and functional integration. The long-term goal of this proposal is to
define a regenerative strategy by using a patient's own scar-forming cells without cell transplantation. In response
to SCI, perivascular cells proliferate and migrate into the lesion core to form the fibrotic scar. Scar formation is
initially beneficial by restricting damage but ultimately detrimental to neural regeneration through acting as a
physical and chemical barrier to axonal regeneration and growth. The goal of this high risk but high reward
project is to define methods to convert these fibroblasts into neurons. Aim 1 will focus on reprogramming of
fibroblasts into progenitors in vivo. Stem cell factors will be examined. Aim 2 will focus on direct neuronal
conversion of fibroblasts in vivo. Several key neurogenic factors will be examined for induction of neurons.
Results of this work may reveal a regeneration-based therapeutic strategy by targeting the fibrotic scar after SCI.

Public health relevance
Spinal cord injury causes huge financial and emotional burdens to patients and their caregivers in the US. No effective cure exists due to the permanent loss of neurons. The proposed project will define an innovative way to convert scar-forming fibroblasts into neurons for functional repair by using a patient's own cells without transplantation.